Administrative and Data Management Core

PROJECT SUMMARY Administrative and Data Management Core
The Administrative and Data Management (ADMIN) Core oversees all administrative and scientific functions of
the IUSM Alzheimer’s Disease Drug Discovery Center (ADDD CENTER) and will ensure progress and success
via effective communication with key partners and stakeholders, along with establishment of milestones and
metrics. Specifically, the ADMIN Core is responsible for overall management and oversight of 1) scientific
projects that are identified and prioritized by the ADDD CENTER according to the high level milestone structure
and are enabled by the ADDD CENTER Technical Cores, 2) Technical Cores, including the interaction among
ADDD CENTER components and collaborators (NCATS, Purdue University, Indiana CTSI), 3) finances and
resources, 4) internal and external communications with the ADDD CENTER and other AD-relevant
programs/centers (including NIA-supported ADCs/ADRCs) and key initiatives (AD-AMP, ADNI, ADSP, MODEL-
AD, etc.), the scientific community, and the NIA/NIH, 5) evaluation of projects, cores, and the ADDD CENTER
as a whole, and 6) research data dissemination through the Open Access Data Sharing platform and distribution
of Target Enablement Packages to the external community.
The ADMIN Core operates under the leadership of Dr. Alan Palkowitz and Dr. Bruce Lamb at IUSM, and will be
supported by the other Technical Core leaders, namely Dr. Kun Huang (IUSM), Dr. Zhong-Yin Zhang (Purdue
University), Dr. Andrew Mesecar (Purdue University), Dr. Markus Lill (Purdue University) and Dr. Karson Putt
(Purdue University). Additionally, two full-time managers and one administrative assistant will report to Dr.
Palkowitz and oversee the day-to-day management of the ADDD CENTER activities. Finally, the ADMIN Core
will execute its strategic management, evaluation and fiduciary duties through two committees (External Advisory
Board (EAB) and ADDD CENTER Steering Committee (CSC), that will meet biannually and monthly,
respectively), along with other organized administrative and scientific meetings of ADDD CENTER investigators,
staff, collaborators, and advisors, as described below. The Specific AIMS of the ADMIN Core are:
1. Provide effective management, oversight and evaluation of the IUSM ADDD CENTER’s highly
integrated Core activities along with communication to key stakeholders including the Center Steering
Committee, External Advisory Board and the AD Research community.
2. Ensure timely and successful completion of ADDD CENTER aims and delivery on key milestones and
associated criteria.
3. Create and manage a dynamic open sharing data platform that will facilitate broad community access
to all Center experimental activity along with key tools and methods as part of specific Target Enabling
Packages.